CORE--TECHNOLOGY AND MEASUREMENT

DESCRIPTION (Adapted from the Applicant's Abstract): Developmental models place special demands upon behavioral and biological measurement. The designs and procedures must be sensitive to the timing and sequence of events since behavior and biology are seen as integrated bidirectional systems. Precision in the assessment of individual components of the biological and behavioral system is a necessary but not sufficient condition. Biobehavioral investigations including Center project #3 illustrate how an intensive study of behavior development can productively direct biobehavioral analyses, and vice-versa. Accordingly, the aims of the Technology and Measurement Unit are: 1. To provide direction and assistance to the research programs of the Center in their selection of appropriate biobehavioral, psychological, and social network measures; 2. To institute a mechanism for Center research to collaborate in the use and analysis of common behavioral and biobehavioral measures through sharing instruments and measurement strategies; 3. To develop and refine behavioral and neuroscience procedures that may be integrated and employed across the research programs of the Center; 4. To support the publication of monographs that make recent advances in neurobiological, metabolic, and physiological measurement more accessible to researcher in development and behavior; 5. To conduct workshops and conferences on recent advances in assessment, including behavioral/psychiatric linkages to innovations in social measurement and functional brain imaging.